Clinical and Educational Core

The Clinical and Educational Core (CEC;Core 2) will assume Center-wide responsibility for four major components of the ExCITRA (P20), including: 1) the recruitment, screening, diagnostic assessment, and clinical care of all human research participants;2) the comprehensive neurocognitive assessment of all subjects successfully meeting eligibility criteria;3) the concurrent psychopharmacologic characterization of individuals'subjective, behavioral, and neurocognitive responses to stimulant self-administration (cocaine in cocaine dependent subjects) and/or administration (methylphenidate in cocaine dependent and healthy control subjects);and, 4) the coordination of research career development of affiliated trainees in the interdisciplinary and translational neurobiology of drug addicfion.

Public health relevance
The function of the Clinical and Education Core provides direct support to Projects 1 and 2 in the exploratory center and coordinates educational efforts across the enitre Center. Thus the function of the Core is essential to the translational research mission and goals of understanding the neurobiology of drug addiction.